Saccade Target Selection in Naturalistic Visual Search

Rapid and accurate saccadic eye movements of the high-resolution fovea are crucial for performing virtually
any visuo-motor task. Indeed, we typically make more than 180,000 saccades during the waking hours of each
day, and each one of these movements requires the selection of a saccade target. Considering the vast
number of possible saccade targets typically present in natural scenes, saccade target selection is a
computationally intensive process, yet it is one that we accomplish rapidly, without conscious awareness, and
with great precision. This study focuses on the role of the midbrain superior colliculus (SC) in saccade target
selection, as well as its interactions with the cortical frontal eye fields (FEF). When searching for an object, a
number of factors influence saccade target selection, including the physical salience of potential targets, their
similarity to the target being sought, and whether they have already been fixated and rejected as the target.
Most studies have used isolated, point-like stimuli to study target selection, despite the fact that the real world
is composed of spatially extended objects, and that objects are the typically relevant perceptual units for
directed behavior. This project is one of the few that will use extended object-like stimuli to better understand
saccade target selection under more naturalistic conditions. A key advance is that we will use a cutting-edge
information theoretic analysis technique known as time-resolved partial information decomposition (PID). PID
is particularly suited for research questions aimed at a fine-grained understanding of how neurons dynamically
encode a small number of variables over time. This will afford us unprecedented insights into how the SC
combines different sources of information to select a saccade target, and how the selectivity of SC neurons
changes as new information becomes available. PID will also enable us to rigorously test various models of
how the SC integrates salience, target similarity, and inhibitory tagging information during search. Overall, the
project will move the field forward significantly both with its cutting-edge analysis techniques and in its focus on
target selection in more naturalistic scenes involving spatially-extended objects.

Public health relevance
Accurate and efficient saccadic eye movements are essential for performing most visuo-motor tasks, including things like reading, cooking, and driving, and a dysfunctional mechanism for selecting saccade targets would impair all of these everyday activities. These experiments will help to reveal the architecture of the saccadic eye movement system, leading to a better understanding of human neurological syndromes which disrupt eye movements, including hemi-spatial neglect and attention deficit hyperactivity disorder (ADHD).